ArkanSONO: A Technology Based Outreach Exposure Program for High School Students

Abstract
ArkanSONO is a partnership between University of Arkansas for Medical Sciences (UAMS) faculty and Little
Rock School District (LRSD) teachers to bring state-of-the-art hand-held ultrasound imaging and simulation
technology to 9th grade classrooms and invite students and teachers to a weeklong imaging technology and
cardiovascular health focused summer day camp at UAMS. The overall objective is to increase STEM content
knowledge and promote more positive beliefs and attitudes towards STEM with the ultimate goal of promoting
a more diverse STEM workforce. The four specific aims are to: 1) Increase the interest and knowledge of high
school students for STEM related fields and careers. The program uses hand held ultrasound imaging devices
coupled with a high fidelity simulator to stimulate student interest in STEM in both the classroom and in a
weeklong cardiovascular health focused summer day camp (SONOcamp). Three separate classroom sessions
will provide students with hands-on experience using the devices to peer inside the human body at the
functioning heart and peripheral vasculature. Students will use critical thinking skills and principles of scientific
investigation to predict and experimentally test how common objects will look under ultrasound imaging
(phantom model). The SONOcamp experience will include using ultrasound in standardized patients, inspect
isolated cadaveric organ specimens and whole body CT scans that demonstrate cardiovascular related
pathologies, participation in luncheon panel discussions with STEM role models, and tours of sophisticated
imaging technology facilities. The camp will be capped off with a friendly team-based SONOlympics
competition and Career and Health Fair. A SONOpeer program will allow a subset of students to work as team
leaders in SONOcamp. 2) Increase STEM content knowledge and familiarity with imaging in students and
teachers. Teachers will be invited to a 2-day workshop to be trained as ultrasound facilitators and refine the
planned outreach curriculum. Teachers and a subset of students will be invited to the active learning
experiences in SONOcamp. 3) Increase knowledge and understanding of the link between diet, exercise, and
genetics to the risk of cardiovascular related disease. The underlying theme throughout all ArkanSONO
outreach activities will be cardiovascular health and disease. Group experiments in SONOcamp will enlighten
students on the interrelationship of the cardiovascular system and other organs. 4) Develop an innovative
ultrasound technology based interactive website that can serve as a resource for STEM teaching and learning.
The ArkanSONO website will be designed as an interactive website geared towards P-12 students and
teachers to facilitate adoption of the ArkanSONO approach. It will also include a virtual phantom module that
can be used by classrooms across the US when access to ultrasound technology is lacking. The successful
implementation of ArkanSONO will serve as a model for using ultrasound technology to promote STEM in
diverse populations to ensure a future STEM workforce that better reflects the US population.

Public health relevance
Project Narrative ArkanSONO is an outreach program for 9th graders in the Little Rock public school system that takes advantage of technological advances in simulation and ultrasound technology to provide students with an opportunity to experience first hand the transformative power of these new educational tools. The program uses these technologies in the classroom and in a weeklong cardiovascular health focused summer day camp to stimulate student interest in STEM and health related careers and to increase student and teacher STEM content knowledge and familiarity with imaging technology. The successful implementation of the ArkanSONO program will serve as a unique model for attracting students towards a STEM career to ensure that the STEM workforce of the future better reflects the diverse population of the US.